Longitudinal Biomechanics and Patient-Reported Outcomes after Periacetabular Osteotomy for Developmental Dysplasia of the Hip

Project Summary/Abstract
Developmental dysplasia of the hip (DDH) is a life-long disorder that alters joint biomechanics and increases
the risk of early osteoarthritis. The most common treatment for DDH is periacetabular osteotomy (PAO), which
surgically reorients the abnormally shaped acetabulum to better cover and stabilize the femoral head. After PAO,
patient reported outcome measures (PROMs) improve for many, but not all, patients, and PROMs for most
patients remain below the levels of their healthy peers. Recent work has shown that aberrant biomechanical
variables, including disproportionate joint reaction forces, high acetabular edge loads, and low abductor muscle
strength, are related to specific geometric deformities in DDH prior to PAO. These altered biomechanics are also
related to worse PROMs. The current project seeks to optimize surgical care for DDH by determining the effects
of, and relationships among, PAO-induced changes to hip geometry, biomechanics, and PROMs. The overall
goal of the parent R01 project is to rigorously investigate how periacetabular osteotomy changes hip
biomechanics and how those changes are associated with patients’ activity levels and self-reports of function,
pain, and quality of life during the first year after surgery. This supplement request in response to PA-23-189:
Research Supplements to Promote Diversity in Health-Related Research (Admin Supp Clinical Trial Not Allowed)
will support the training and career development for a PhD student whose long-term goal is to be a senior-level
independent investigator at the crossroads of biomechanical engineering, orthopedics, and movement science.
The supplement scholar will enhance the impact of the parent R01 by investigating the morphology and
biomechanics of the contralateral hip in patients with DDH who receive PAO. Many patients present with bilateral
evidence of DDH but only unilateral symptoms. After PAO, half of patients develop contralateral hip symptoms
and thirty percent receive hip preservation surgery. Thus, the contralateral hip is an important component in the
overall treatment of patients with DDH and in our understanding of DDH as an osteoarthritis precursor. The
supplement scholar will also receive customized training and mentoring to foster her growth as a scientist. It is
expected that this supplement will provide the scholar foundational training to progress to her next career step
and enable her to advance as an important voice of under-represented senior investigators in the biomedical
sciences.

Public health relevance
Project Narrative Developmental dysplasia of the hip dramatically increases the risk for early hip osteoarthritis in adolescents and young adults, and is usually treated surgically with a periacetabular osteotomy. The current project will rigorously investigate how periacetabular osteotomy changes hip biomechanics and how those changes are associated with patients’ activity levels and self-reports of function, pain, and quality of life during the first year after surgery; it will also provide critical training opportunities to a trainee that will promote diversity in health- related research.